Multiscale Simulation of Key Biomolecular Processes in the Cell

PROJECT SUMMARY
Biological membranes, protein-protein interactions, and membrane targeting and remodeling by proteins
are intimately associated with many critical cellular phenomena, including endocytosis, immune response,
organelle formation, cell division, signaling, and movement. These processes are inherently multiscale, as they
span from the molecular to nanoscopic to mesoscopic time and length scales. For instance, the molecular-level
interactions between collections of proteins and the lipid membrane can have a profound effect on the large
scale membrane morphology. Likewise, the atomistic details of actin and actin-binding protein interactions
propagate to much longer length and time scales involving protein assembly processes in the cellular
cytoskeleton. The interactions of cytoskeleton proteins with membranes are key to many phenomena, including
cellular adhesions and motility. Therefore, the main scientific premise of this project is that it is critical to study,
in an integrated and coupled fashion, the propagation of local molecular interactions upward in scale to the
collective behavior at the cellular level. This research also involves the ongoing development and application of
novel multiscale, coarse-grained (CG) computational methods that are ideally suited to investigate the collective
interactions of proteins with other proteins and with membranes, including details about conformational states
and reactive systems, within the context of key cellular phenomena.
There are three main overarching themes of this research that involve the study of increasingly complex
aspects of large scale protein-protein complex formations and protein-mediated membrane remodeling
processes. These are: (1) employ bottom-up CG models to study realistic membrane systems including
peripheral membrane proteins, (2) study the mechanism of large-scale formation and remodeling of actin-based
networks as mediated by interactions with actin-binding proteins, and (3) elucidating the mechanisms of protein-
mediated remodeling of membranes involved in cellular processes such as the formation of micron-size
structures like filopodia and lamellipodia, topological changes such as endocytosis, and dynamic processes
such as cell migration with continuous actin turnover. In collaboration with leading experimental researchers to
both confirm simulation predictions and to validate the simulation-generated hypotheses, the overarching long-
term goal of this research is to continue to apply powerful and systematic multiscale computational approaches
to the study of realistic biomolecular processes underlying various important cellular phenomena. These
phenomena range from specific interactions at the molecular scale to the concerted action of thousands of
proteins.

Public health relevance
PROJECT NARRATIVE This project concerns the development and application of multiscale computer simulation methods to study key biomolecular processes in the cell involving membranes, membrane proteins, cytoskeleton filaments, cytoskeleton-associated proteins, and cytoskeleton-membrane interactions. The specific systems to be studied have been implicated in a wide range of cellular phenomena pertinent to disease, including endo- and exo- cytosis, cellular trafficking, centronuclear myopathy, cancer, Alzheimer’s disease, and cell invasion. 1